Investigating genes of unknown function required for Rickettsia parkeri infection

PROJECT SUMMARY/ABSTRACT
Intracellular bacterial pathogens manipulate host cells through a vast array of mechanisms. Studying these
interactions has propelled our understanding of therapeutic development against these pathogens and host cell
biology. However, many intracellular pathogens cannot be easily studied due to their obligate nature and
resistance to genetic manipulation. These include the spotted fever group (SFG) Rickettsia, which cause a range
of potentially severe arthropod-borne human illnesses, including Rocky Mountain spotted fever. The
development of new random mutagenesis systems for SFG Rickettsia has propelled studies of these microbes
and hinted at the remarkable diversity of unprecedented pathogen innovations in this genus. Recently, our lab
performed a small-scale transposon mutagenesis screen in the model rickettsial species R. parkeri to identify
attenuated mutants. This screen led to the isolation of >100 R. parkeri mutants with infection defects, with only
a few containing insertions in genes previously linked to R. parkeri virulence. The remaining strains represent a
valuable tool for probing and understanding R. parkeri and intracellular pathogen biology. Over 15% of the genes
hit in this screen are unannotated. Two of these unannotated genes, hrtA and sp50, encode R. parkeri proteins
that are predicted to be surface-exposed or secreted and have putative structural features suggestive of direct
binding to host proteins. I hypothesize that HrtA and Sp50 are novel R. parkeri secreted or surface-exposed
effectors that can hijack specific host functions to promote infection. In this proposal, I will first demonstrate the
spatiotemporal niches of both HrtA and Sp50 (Aim 1) to establish how they phenotypically contribute to R. parkeri
infection. Then, I will use affinity purification approaches to identify direct host-derived interactors of HrtA and
Sp50 (Aim 2). Finally, I will use host-direct genetic perturbation screens to profile host-pathogen synthetic genetic
interactions with R. parkeri strains lacking HrtA or Sp50 (Aim 3). Through this work, I will not only extend our
understanding of SFG Rickettsia pathogenesis, but will also demonstrate the potential of a synthetic genetic
approach for investigating and annotating pathogen genes of unknown function. Results from these studies may
also inform development of therapeutics such as vaccines against SFG Rickettsia species.
The training environment at MIT, where this project will be carried out, is outstanding and highly collaborative.
All facilities and equipment required for this project are available to the applicant (Dr. Brandon Sit). The training
plan accompanying this project involves the joint mentorship of Dr. Sit by Drs. Rebecca Lamason (primary
sponsor) and Paul Blainey (co-sponsor), and is designed to position Dr. Sit for a transition to an independent
investigator position at the end of this work.

Public health relevance
PROJECT NARRATIVE Pathogens in the Rickettsia genus cause an array of potentially fatal arthropod-borne vascular diseases in humans, but their infection mechanisms are poorly understood. The goal of this project is to investigate how two Rickettsia surface or secreted proteins of unknown function promote infection of host cells. Knowledge from this work will improve our understanding of Rickettsia pathogenesis and directly inform the development of diagnostics, therapeutics, and vaccines for these pathogens.